Cytosolic Access and Instability of DNA nanoparticles

PROJECT SUMMARY/ABSTRACT: A number of candidate therapies such as CRISPR-Cas9 and gene
silencing require the efficient delivery of functional nucleic acids to the cell cytosol and nucleus. Unfortunately,
such therapies currently lack proper delivery mechanisms, precluding their widespread applicability. Self-
assembled deoxyribonucleic acid (DNA) nanoparticles have shown potential as minimally cytotoxic
therapeutic carriers in cancerous and other in vitro and in vivo models. While evidence suggests that DNA
nanoparticles-based drug carriers can be taken up by mammalian cells via endocytosis, it is unknown
how these DNA nanoparticles can overcome the fate of endocytosis-triggered degradation to reach
the cytosol and, once there, can controllably maintain stability. With the enabling science explaining
their behavior and mechanisms of controlling their stability in the cell cytosol it will be possible to make bold
advances in engineering therapeutic delivery systems. To that end, the proposed work has two overarching
scientific payoffs. Payoff 1, induce endosomal escape and enhanced cytosolic accessibility of DNA
nanoparticles by the integration of calcium in their assembly process. Payoff 2, identify the rate of
breakdown and mechanisms of stabilization of DNA nanoparticles in different types of cell cytosols.
Innovative technologies will be the foci of the PI's training program and will be implemented to achieve the
project goals, namely, multi-step Förster resonance energy transfer spectroscopy for high-resolution
tracking of DNA nanoparticle inside the cell and in vitro cell microinjections enabling study of these
nanoparticles directly in the cytosolic environment. First, a DNA origami based nanotube will be tested for
structural stability in calcium-supplemented buffer. Thereafter, the nanotube will be used as a carrier for
the delivery of functional RNA molecules to representative fluorescent protein-expressing cells and checked
for its cytosolic reachability and efficacy in protein regulation after undergoing endocytosis. Second, small
(20 nm) DNA nanoparticles with branched architecture and non-canonical nucleic acids will be embedded
with multi-step FRET reporters for measuring structural integrity. These DNA nanoparticles will be
microinjected into live cells cytosolic region and their breakage be determined. Last, the cytosolic stability
of these DNA nanoparticles will be correlated with different types of mammalian cells with known cytosolic
variability (tumor, immune, and other cell types) in order to map the role of structurally diverse DNA
nanoparticles in targeting cells with different physiologies. The PI will also receive training in rigorous
analysis of in vitro research, lab management, and the prolific grant writing process, which will facilitate
their transition to an independent research program. Outcomes of this project will pave the way towards
developing more bio-compatible delivery systems, specifically for functional nucleic acid therapeutic agents
that are vital in the cell cytosol.

Public health relevance
PROJECT NARRATIVE Synthetic DNA-based nanoparticles possess the potential to develop advanced delivery tools for targeted therapies, but their behavior in the cytosolic environment remains poorly understood. Herein, we seek to address critical issues about the accessibility and breakdown of these nanoparticles within the mammalian cell cytosol and identify mechanisms of stabilization. Outcomes of the proposed project will enable the realization of more- biocompatible delivery systems.